Using PNAs to Elucidate the Role of G-quadruplex and Hairpin Structures in ALS/FTD through a Combined Biophysical and Computational Approach

Amyotrophic lateral sclerosis (ALS), a fatal neurodegenerative disorder resulting in motor neuron loss in the brain and spinal cord, and frontotemporal dementia (FTD), a degenerative condition of the brain frontal and anterior temporal lobes, are multisystem disorders with overlapping functional and genetic causes. In 2011 it was discovered that a hexanucleotide GGGGCC expansion in the C9ORF72 gene is a common genetic cause for ALS and FTD, however, the mechanisms by which this repeat expansion leads to ALS/FTD are not clearly understood. The proposed research will contribute to our understanding of these molecular mechanisms by providing direct information on the structures adopted by the sense/antisense RNA of variable lengths produced through the transcription of the C9ORF72 GGGGCC expansion repeats, as these transcripts have been proposed to play central roles in the pathology of these diseases. This study advances the hypothesis that peptide nucleic acids could be developed as molecular tools to characterize the structures formed by the C9ORF72 sense (G4C2)/antisense (G2C4) transcript RNAs and potentially to disrupt their interactions with RNA binding proteins, and has the following specific aims: Specific Aim I. Characterization of the C9ORF72 hexanucleotide expansion sense (G4C2) and antisense (G2C4) transcript structure(s). Our preliminary results indicate that the sense (G4C2) expansion repeat RNA forms G quadruplex structures that co-exist in equilibrium with hairpin structures. We will use an array of biophysical methods to characterize the structures formed by the C9ORF72 sense (G4C2) expansion repeat RNA, specifically analyzing the influence the repeat length and other factors (salt dependence, folding conditions and time) have upon the equilibrium between them. Additionally, to determine how RNA binding proteins affect this equilibrium we will analyze by both biophysical and computational chemistry methods the interactions of the sense (G4C2) expansion repeat with the fragile X mental retardation protein and with FUS, proteins that others and we showed bind G quadruplex RNA structures. Subsequently, similar biophysical methods will be used to characterize the structure(s) formed by the antisense (G2C4) RNA transcript that has not previously been structurally characterized. Specific Aim II. Development of peptide-nucleic acids that bind specifically to either G quadruplex or hairpin structures formed by the C9ORF72 expansion sense (G4C2) and antisense (G2C4) transcripts. Organic synthetic methods will be used to synthesize γ-modified peptide-nucleic acid (γPNA) molecules designed to recognize specifically the structures formed by the C9ORF72 expansion sense/antisense expansion repeat transcripts. The interactions of the γPNAs with their designated targets will be characterized by biophysical and computational chemistry methods, and subsequently their ability to prevent the interactions of the C9ORF72 expansion sense/antisense transcripts with RNA binding proteins will be investigated.

Public health relevance
This is a detailed study of the structures formed by the RNA transcripts from the C9ORF72 hexanucleotide repeat expansion, that has been shown to cause amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD), and of their interactions with gamma-modified peptide nucleic acids developed as both, diagnostic molecular tools and potential therapeutic agents. The results of this study will contribute to our understanding of the molecular mechanisms that cause ALS/FTD.